RAND REACH Center

Summary
All complementary and integrative healthcare (CIH) educational programs include both bioethics and
Evidence-Informed Practice (EIP) as part of their curriculum. However, they are not taught in tandem. A strong
bioethical case can be made that practicing EIP has a bioethical basis in that all patients, under bioethical
principles such as beneficence, have the right and the expectation to be treated with therapies that are
evidence informed. This also pertains to the bioethical principles of non-maleficence, veracity, autonomy,
fidelity and justice – each would imply that the EIP does not violate these principles. Yet to implement EIP, a
health professional must be able to determine the validity, reliability, appropriateness, robustness and safety of
the therapy for which the evidence has been collected. That in turn requires a basic level of literacy in research
methods. While it is impractical to expect all healthcare providers to possess the research literacy of trained
researchers, a certain level of understanding is essential for them to evaluate the relevance of evidence to their
patients; thus, EIP becomes not only a necessity but also a bioethical obligation.
This proposal is for a one-year supplement to the NCCIH U24-supported RAND Research Across
Complementary and Integrative Health Institutions (REACH) Center, in response to the NIH NOSI
Administrative Supplement for Research and Capacity Building Efforts Related to Bioethical Issues. The
proposed project focuses on capacity building in bioethics. Specifically, we would develop and disseminate a
Virtual Training Program on the Bioethical Basis for EIP, targeting faculty, researchers, and students at RAND
REACH member institutions as well as practicing professionals through Continuing Education (CE)-eligible
training. The program will address the dual challenges of bioethical practice and EIP adoption. CE programs
will be used as an efficient way of implementing the objective of this project into the wide practicing community.
The training program will consist of 10 virtual modules focused on the bioethical dilemmas involved in
determining EIP across the range of evidence-producing methods. The relevance and quality of the modules
will be enhanced through input from a Bioethics/EIP Working Group comprising CIH clinician scientists and
practitioners. The virtual program will be offered free of charge and distributed through CIH educational
institutions (including those not currently RAND REACH members), enabling them to incorporate it into their
curriculum and CE offerings. Accreditation for CE credits will serve as an implementation strategy to
encourage widespread adoption among those in practice.

Public health relevance
Project Narrative While evidence-informed practice (EIP) is a cornerstone of healthcare education, it should also be a bioethical imperative for practice. Patients have the right to expect that their healthcare is based on evidence – and the bioethical principle of beneficence should ensure it – yet currently bioethics and EIP are not linked in CIH training or continuing education. In this project, 10 virtual modules on EIP and bioethics will be developed to be used in CIH education and delivered to faculty, students and practitioners, at no cost to the CIH professions.